Dynamically reconfigurable materials for 4D bioprinting of a human gut-brain axis

Project Summary
Significance: Disorders of gut-brain interaction (DGBIs) impact tens of millions of Americans yet remain poorly
understood due to their complex etiology across multiple tissues. Our growing understanding of the importance
of the gut-brain axis, nicknamed the “second brain,” is also hindered by a lack of suitable animal and cell culture
models. However, there is consensus on the importance of the enteric nervous system (ENS) in DGBIs and
growing evidence of their genetic and molecular profiles. Therefore, bottom-up tissue engineering platforms
could improve our basic understanding of gut-brain axis development and associated diseases through
mechanistic insight into its self-organization and morphogenesis. This Pathway to Independence Award
proposes to develop 4D bioprinting, a method that provides spatial and temporal cues to guide tissue
development in time, toward construction of a human gut-brain axis using stem cell-derived assembloids.
Innovation: This proposal hypothesizes that reconfigurable bioprinting materials will enable guided tissue self-
organization and morphogenesis in a process mimicking development. This will be tested by developing
composite materials comprised of (1) granular microgels that permit reconfiguration and (2) interstitial materials
that provide key biochemical and viscoelastic signals (Aim 1). These matrices will enable construction of stem
cell-derived assembloids of human intestine and ganglia at different developmental timepoints (Aim 2). Finally,
microfluidic perfusion will facilitate better models DBGI-relevant processes, such as impaired peristalsis, and
resulting changes to ENS gene expression (Aim 3). Broadly, the proposed work will establish new design rules
for tissue engineering and new living materials for bioprinting and 3D cell culture applications.
Candidate and Environment: Dr. Austin Graham is committed to leading an independent research group that
addresses unmet biomedical challenges through the design of living materials and engineered tissues. He has
a strong research and mentorship track record, including a recent publication on the development of living
materials for organoid bioprinting and morphogenesis as well as research, teaching, and mentorship awards
from the Materials Research Society and National Science Foundation. Through his postdoctoral fellowship, he
has established an interdisciplinary advisory team that leverages the top research quality and unique
collaboration between UCSF and the Chan Zuckerberg Biohub. These facilities provide him with the expertise,
equipment, and resources required to successfully achieve the proposed Aims.
Career Development: During the mentored period, the candidate will gain additional training in pluripotent stem
cell culture, transcriptomics, and mouse genetics, in which his advisory team are hands-on experts. The
proposed work will provide the candidate with a unique expertise in developing living materials for 4D bioprinting.
This will position the candidate to start his own research program with interdisciplinary focuses on bioengineering
(e.g. living materials for human organoids) and mechanobiology (e.g. peristaltic dysregulation in DGBI).

Public health relevance
Project Narrative Disorders of gut-brain interaction (DGBIs) impact tens of millions of Americans, yet their etiology is poorly understood partly due to the difficulty in modeling complex multi-tissue systems in vitro or in vivo. 4D bioprinting is a technique that synergizes 3D spatial conditions and developmental time using living materials that provide mechanical and biochemical cues to guide self-organization. This conceptualization will enable construction of a human gut-brain axis with functional epithelium and enteric nerve by mimicking in vivo development.